Community-Based Opioid Treatment (CBOT): Development and testing of a novel nurse-led model to deliver opioid use disorder treatment and HIV prevention and care in the community setting.

PROJECT SUMMARY
People who use opioids (PWUO) are at increased risk of drug overdose as well as HIV infection or worse HIV
outcomes. Retention in opioid use disorder treatment and HIV prevention or treatment (hereafter referred to as
HIV care) for PWUO remains suboptimal. Medications for opioid use disorder are gold standard treatments for
opioid use disorder (OUD). This includes buprenorphine which has a strong evidence base in reducing the risk
of overdose, reductions in drug use, soft-tissue infections, and hospitalizations. Additionally, buprenorphine
treatment been shown to improve HIV care outcomes by engaging in PWUO in health care services to reduce
infection risk as well as promoting HIV viral load suppression for PWUO living with HIV. While there are
successful clinic-based implementation strategies to improve buprenorphine and HIV care access, long-term
retention, particularly at 1 year, remains elusive. Achieving this long-term retention goal requires innovations in
delivery of these services. Community-based care is a means of service delivery which prioritizes individuals at
high risk of falling out of care and/or poor HIV care outcomes with care services delivered directly to them. The
propose of this study is to develop the Community-Based Opioid Treatment (CBOT) implementation strategy to
deliver buprenorphine and HIV care services to PWUO by nurse care-managers and community outreach
workers and then conduct an implementation trial comparing the implementation and clinical effectiveness
outcomes of CBOT compared to evidence-based, clinic delivery of opioid treatment. Part 1 of the study will
consist of interviewing patients, providers, nurses, and other stakeholders to inform development of CBOT and
the blueprint needed to implement this care delivery strategy. Part 1 will conclude with a 3-month pilot of CBOT
with n=10 participants, and any needed refinement of the CBOT implementations strategy. Part 2 of the study
will be a type-3 hybrid implementation trial. Participants (n=140) will be randomized (1:1) to receive the CBOT
implementation strategy for opioid use disorder treatment and HIV care services delivered by a nurse care-
manager and community outreach workers or office-based opioid treatment, with opioid use disorder treatment
delivered by a nurse care-manager in the clinic setting. Primary implementation outcomes include the
feasibility, acceptability, and maintenance of the CBOT implementation strategy. Secondary clinical outcomes
are buprenorphine retention and HIV care outcomes (HIV viral load or uptake of HIV testing). Finally, costing
measures will be continuously collected to conduct micro-costing analysis. CBOT can be the next tool that
clinics and health systems utilize to successfully reach PWUO at risk for or living with HIV who are at high risk
of falling out of care and prioritizing them for enhanced services. In summary, this study addresses a pressing
need to determine the most effective approach to retention in opioid use disorder treatment and HIV care for a
priority population of individuals at high risk of a drug overdose and falling out of established care.

Public health relevance
PROJECT NARRATIVE People who use opioids are at increased risk of poor retention in opioid use disorder treatment and HIV care services (HIV treatment or prevention). This study will develop and test a novel implementation strategy for the delivery of opioid use disorder treatment and HIV care services in the community setting by nurses and community outreach workers. The overarching goal is to improve retention in care opioid use disorder treatment and HIV care services for this population at high risk of falling out of care.